ACUTE CHEST SYNDROME IN SICKLE CELL DISEASE

The purposes of this study are to identify the causes of Acute Chest Syndrome (ACS) in patients with sickle cell anemia and to find out what, if any, long-term damage ACS may cause.